Facial Affect Sensitivity Training for young children with CU traits.

PROJECT SUMMARY
Callous-unemotional (CU) traits (e.g., lack of guilt or remorse, low empathy, shallow affect) are
consistent with the core affective features of adult psychopathy and are an established risk
factor for early emerging, persistent, and severe youth misconduct. CU traits reflect impairment
in identified neurocognitive mechanisms that interfere with child socialization and predict poorer
treatment outcomes, even with well-established treatments for disruptive behavior, and thus call
for novel interventions. Prominent theories that attempt to account for the failure of those with
CU traits to recognize, and respond appropriately to, others' emotional distress all emphasize
fundamental deficits in affect sensitivity, including reduced attention toward and recognition of
others emotional cues, particularly signals of distress (e.g., facial expressions of fear, sadness).
On the other hand, high-CU youth show normal to exaggerated reward responsivity. We assert
that impaired sensitivity for emotional distress cues (fear and/or sadness) is mechanistically
linked to CU traits in children, and that by targeting facial affect sensitivity (FAS) directly via a
computerized automated feedback and incentive system, we can exert downstream effects on
CU traits. We thus propose an experimental therapeutics approach to develop and test a novel
neurocognitive intervention for CU traits. The first phase (R61) of the proposed project will
demonstrate, in a preliminary randomized controlled trial (RCT; N=30), that a new
neurocognitive intervention (Facial Affect Sensitivity Training: FAST) can engage the target,
FAS (measured primarily by FER accuracy for distress expressions, and secondarily by
heightened eye gaze and neural activity) in children with elevated CU traits. We will examine
individual growth rates and test slope differences between conditions (FAST v control). Target
engagement will be defined as medium effect size (d > .40) in the comparison of FAST vs. no-
treatment control on the primary target (distress FER). We will also aim to determine optimal
dose parameters with regard to number of sessions for FER improvement (e.g., timing of local
bump or decay, amount of change, when maximal change occurs), and participant satisfaction
with session frequency, length, and number. In the R33 phase, we aim to replicate target
engagement with a new, larger high-CU sample, and evaluate feasibility and preliminary
efficacy of FAST, in the context of an RCT (N = 50) in which FAST is compared to an active
control condition (ACC; implicit eye gaze training), including examining downstream change in
CU traits. If the FAST intervention improves FER and reduces CU traits, such training in early
childhood could help interrupt the developmental cascade toward antisocial outcomes.

Public health relevance
PROJECT NARRATIVE Certain traits in children such as shallow emotions and lack of empathy or remorse, otherwise known as callous-unemotional (CU) traits, increase their risk for violent antisocial behavior and seem to reflect difficulties in recognizing distress-related expressions like fear and sadness. We assert that impaired facial affect sensitivity (FAS) to others' emotional distress is linked to the development of CU traits in children and that, by targeting FAS directly, in particular, facial emotion recognition (FER) for distress, we can exert downstream effects on CU. We propose a new treatment for CU traits, in which we have a clear treatment target (FER) that we will improve and, in turn, reduce CU behaviors.